NIDCD Core for Clinical Research and Care

The NIDCD Core for Clinical Research and Care supports the following NIDCD projects:
1 ZIA DC000039 Identification of Genes Causing Syndromic and Nonsyndromic Hearing Impairment
1 ZIA DC000046 Genetic Studies of Human Communications Disorders
1 ZIA DC000060 Molecular Analysis of Human Hereditary Deafness
1 ZIA DC000064 Clinical Analysis of Disorders Of Hearing And Balance
1 ZIA-DC-000082 Neurotology Program
1-ZIA-DC-000088 Cellular and Molecular Pathogenesis of Hearing Restoration in Adult Inner Ear

The NIDCD and collaborative protocols supported by the core include:
IRB002331 - Central Mechanisms in Dysosmia
OH93-DC-0016 - Nonsyndromic Hereditary Hearing Impairment Gene Mapping: India / Pakistan Protocol
97-DC-0180 - Genetic Analysis of Human Hereditary Hearing Impairment
01-DC-0228 - Clinical and Molecular Analysis of Hearing Impairment with Enlarged Vestibular Aqueducts
01-DC-0229- Genetic Analysis of Hereditary Disorders of Hearing and Balance
12-DC-0152 - Normative values in audiovestibular testing
17-DC-0138 - Cisplatin and statins in ototoxcity
18-DC-0051 - NIDCD Biospecimens protocol
20-DC-0047 - Natural History and Genome Editing in Dominant Hearing Loss
21-DC-0002- Phase III Interventional Study using Atorvastatin to Reduce Cisplatin-Induced Hearing Loss
21-C-0009 - A Natural History Study of Children and Adults with Olfactory Neuroblastoma
000077 Clinical Data and Specimens in head and neck disorders
000141 Hearing Instability Phenotyping
15-D-0129 Dose-Escalation Study Evaluating the Safety of a Single Administration of an Adeno-Associated Virus Vector Encoding Human Aquaporin-1 in Irradiation-Induced Parotid Salivary Hypofunction
04C0165 - Data Collection, Clinical Care and Interventions in CCR, NCI
001572 - A Phase II Study of Bevacizumab in Adults with Recurrent Respiratory Papillomatosis (RRP)
21C0013: PRGN-2012 in Recurrent Respiratory Papillomatosis
20C0024: Neoadjuvant IO for head and neck squamous cell carcinoma
20C0104: Combo Immunotx in HPV oropharyngeal squamous cell carcinoma
000462: ASP-1929 Photoimmunotherapy

The NIDCD Core for Clinical Research and Care supports over 3,000 outpatient clinic evaluations per year. Core otolaryngologists perform 50-100 major surgical cases annually. Staff mentor medical students during senior clinical clerkships. The Otolaryngologist Surgeon Scientist Career Development Program is coordinated through the OCD.